Evolving understanding of HIV-1 reverse transcriptase structure, function, and inhibition.

During the first 30 years of this grant, using X-ray crystallography, we have been able to describe the detailed
molecular architecture of HIV-1 reverse transcriptase (RT) in complex with dsDNA, RNA/DNA, and dsRNA.
These include structures poised for nucleotide incorporation, catalytic complexes, and post-incorporation
structures prior to translocation. All of them represent key states for understanding the comprehensive nature
of reverse transcription during HIV infection, and the mechanisms of action of and resistance to nucleoside RT
inhibitor (NRTI) drugs. In a collaborative effort, our crystallographic structures enabled the discovery of two
non-nucleoside RT (NNRTI) drugs (rilpivirine and etravirine), leading to five licensed anti-AIDS medications.
During the previous grant period, major highlights included solving RT structures in complex with a dsRNA
initiation complex prior to nucleotide incorporation, RT/DNA with an NNRTI, RT with NRTI drugs, and RT with
nucleotide-competing RT inhibitors (NcRTIs) including INDOPY-1. We propose to follow up by determining a
series of RT/DNA-RNA/RNA structures to map molecular details of how first-strand DNA synthesis is initiated,
with a focus on conformational changes in RT and nucleic acid that accompany the transition from initiation
(slow) to processive (fast) DNA synthesis. Similarly, details of second-strand initiation will be probed beginning
with a structure of RT with the polypurine-tract RNA primer across from a DNA template. Additional HIV-1 RT
structures with drugs and investigational inhibitors will be determined to further understand mechanisms of
inhibition and resistance, and the potential for additional sites not currently targeted by anti-AIDS drugs.
Although the HIV proteins and enzymes are produced initially as part of Gag-Pol precursor polyproteins,
relatively little is known about the detailed structure and function of the immature forms prior to maturation.
Recently, we have produced multiple-milligram amounts of the HIV-1 Gag-Pol and Pol precursor polyproteins
for the first time. Cryo-EM determination of the HIV-1 Pol polyprotein shows a dimeric structure with RT in a
p66/p51 heterodimer-like configuration at its core, suggesting that formation of the mature RT structure is
guided from early stages of its morphogenesis. Formation of the RT dimeric core also brings the protease
monomers into a dimeric arrangement, thus providing structural insight into the potential role of RT in protease
activation during virion maturation. We will pursue further cryo-EM, crystallographic, and biophysical studies of
the HIV-1 Pol polyprotein and its complexes with relevant binding partners to provide further structural and
biophysical insights that shed light on various aspects of virus assembly and maturation.
The proposed work relies on collaborations with Jeffrey DeStefano (Maryland), and Stephen Hughes (NCI-
Frederick), Mamuka Kvaratskhelia (Colorado-Denver), Ronald Levy (Temple), Dmitry Lyumkis (Salk), Stefan
Sarafianos (Emory), and Gilda Tachedjian (Monash).

Public health relevance
Project Narrative HIV-1 reverse transcriptase (RT) is a central target for antiviral treatment of AIDS and detailed knowledge of its structure and function has important clinical and biological consequences. Reverse transcriptase inhibitors figure prominently in almost all HIV/AIDS treatment regimens, including combination therapies that are used in highly-active antiretroviral therapy (HAART) and pre-exposure prophylaxis (PrEP) as well. The proposed studies will enhance opportunities for targeting known and new sites on RT, both as the mature enzyme and during morphogenetic stages in which RT forms part of long precursor polyproteins.